Advancing METASPACE and Spatial Metabolomics for Cancer Research

SUMMARY
Spatial omics are revolutionizing cancer biology by uncovering the intricate molecular architecture of tissues and
solid tumors. They provide unprecedented insights into the tumor microenvironment, cell-cell heterogeneity, and
interactions, helping map in situ cancer-associated cellular reprogramming. Additionally, spatial omics
complement traditional histology techniques, adding novel molecular layers to the interrogation of solid tumors.
Metabolism has re-emerged as a key factor in cancer and cancer therapy. While metabolic reprogramming, and
particularly the Warburg effect, have been traditionally recognized as cancer hallmarks, recent developments
reveal the regulatory roles of metabolites and their functional impacts on cancer cells, immune cells, and other
contributors to the tumor microenvironment. Addressing the need for spatial biology and understanding
metabolism of cancer in situ, spatial metabolomics was established as a technology able to detect metabolite
abundances in tissues at near-single-cell resolution. Cancer biology is a key application of spatial metabolomics,
as evidenced by numerous publications and grants in this field. It has provided insights into multiple applications
in cancer research, including mapping metabolism of the solid tumor microenvironment at near-single-cell
resolution, resolving metabolism of cancer cells and other cell types, conducting drug disposition studies for
bioactive drug metabolites, correlating metabolic responses to detected drugs and metabolites in a dose-
dependent manner, and performing molecular histology. Spatial metabolomics, commonly performed using
imaging mass spectrometry, generates large and complex datasets, making data analysis critical for interpreting
the data in cancer research and translating findings into actionable insights. To address this challenge, we
previously developed METASPACE, a free and open-source cloud software platform for spatial metabolomics.
METASPACE addresses a key problem in the field—metabolite identification—and provides a broad spectrum
of features for experiment planning, quality control, data visualization, analysis, management, and sharing. The
overarching goal of this project is to advance METASPACE, increase its utility, and accelerate the adoption and
impact of spatial metabolomics in cancer research.

Public health relevance
NARRATIVE This project aims to advance METASPACE, a cloud platform for spatial metabolomics, enhancing its capabilities and fostering its adoption in cancer research. By implementing machine learning-based metabolite identification, improving data quality and interoperability, and reducing adoption barriers through training and collaboration, we will drive new discoveries in cancer biology. Ultimately, these efforts will improve cancer diagnosis, treatment, and patient outcomes.